Molecular mechanism of natural killer cell recognition

PROJECT SUMMARY
Natural killer (NK) cells are the major effector lymphocytes of innate immunity that play a critical role in the
immune surveillance of cancer and infection. NK cells distinguish between healthy and abnormal cells by using
an array of activating and inhibitory receptors to recognize their respective ligands expressed on a target cell.
NK cell recognition determines the education, development, differentiation, function and memory of an NK cell.
Thus, understanding the molecular mechanism of NK cell recognition is of critical importance in immunology.
NK cell recognition has following important characteristics: (1) it is dynamic – NK cell recognition is governed
by the transient receptor-ligand interactions at the live cell membrane, (2) it is complex – multiple receptor-
ligand interactions function together to determine the responsiveness of an NK cell, (3) it is specific – NK cells
can discriminate between healthy and abnormal cells, (4) it is safe – NK cell activation is stringently controlled
by inhibitory receptors to avoid inadvertent stimulation, (5) it is a binding-signaling coupled process – an NK
cell is able to translate its binding events to cellular signals, and (6) it is a signaling integration process. This
complexity reflects the uniquely demanding nature of NK cell recognition, which requires simultaneous
detection of multiple ligands on the surface of the target cell being surveyed, precise propagation of
recognition signals across the cell membrane, rational integration of activating and inhibitory signals, and fine-
tuning of NK cell immune responses. The importance and complexity of NK cell recognition has motivated
intensive research for the understanding of the fundamental molecular mechanism. Many models have been
proposed but the molecular mechanism governing NK cell recognition remains elusive. The main problem in
most studies is the inability to directly measure in situ receptor-ligand interactions with single-molecule
resolution, simultaneously visualize real-time live NK cell signaling at the single-cell level, and comprehensively
determine the functional phenotypes of individual NK cells. Here we propose an integration model that an NK
cell determines its activation threshold by integrating the strength and amplitude of different activating and
inhibitory signals from an encountered target cell (responsiveness) and then adjusts it to determine the future
threshold for activation upon a new encounter (memory). To test our hypothesis, we propose to apply our
state-of-the-art single-cell micropipette assays, single-molecule and super-resolution imaging, and single-cell
sequencing technologies, to directly and precisely measure surface molecular interactions, intracellular
signaling, and transcriptome and proteome of single NK cells at the single-molecule level. These data can fully
address the molecular mechanism of signal reception, transduction, integration, and regulation of NK cell
recognition. The results will allow us to test our hypothesis and settle a long-standing question in immunology.
The knowledge gained from this study will greatly advance our understanding of NK cells and will have
important implications for the development of immunotherapy against cancer and infection.

Public health relevance
PROJECT NARRATIVE Natural killer (NK) cells distinguish between healthy cells and abnormal cells. Understanding the molecular mechanism of NK cell recognition will directly advance the understanding, prevention, and treatment of cancer and infection.